Advancing Diagnosis of Dementia in Primary Care Practice(ADDPCP)

PROJECT SUMMARY
As the U.S. population ages, the number of people with Alzheimer’s disease and related neurodegenerative
diseases (NDDs) that cause dementia will grow. Emerging disease-modifying treatments are/will be designed
to address the specific biology of each form of dementia. They are likely to be most effective early in the
course of illness, increasing the importance of prompt and accurate diagnosis. Specific identification of the
cause of cognitive impairment is routine in Neurology and Psychiatry, but exclusive reliance on this limited
workforce for assessment of cognitive and behavioral changes will result in treatment delays with meaningful
clinical impact, particularly for medically underserved communities that face obstacles in accessing specialists.
Early evaluation in the primary care (PC) setting can reduce delays, but PC practitioners (PCPs) identify time
and a lack of confidence as barriers preventing them from assessing cognitive and behavioral complaints.
Biomarkers can facilitate the identification of NDD, but expert guidelines stress that they must be paired with
clinical findings to guide diagnosis. In addition, the available biomarkers only address some of the entities that
cause NDD. The goal of this project is to support more thorough assessment of cognitive and behavioral
complaints in PC by supporting PCPs to use a comprehensive diagnostic toolkit developed by the California
Alzheimer’s Disease Centers. The toolkit includes a pre-visit questionnaire that can potentially shorten future
assessments if the sensitivity of the questions can be established. This project will demonstrate first that
assessment with this toolkit, in combination with regular expert-led case conferences, facilitates accurate
distinction by PC providers of mild cognitive impairment and dementia likely due to Alzheimer’s disease from
other, less typical NDD syndromes, and second, that the implementation of this approach is feasible and
acceptable to PCPs, patients, and families. We will implement the model in five CA PC practices that work with
medically underserved communities to facilitate the assessment of approximately 750 patients by at least 30
PC providers. Each participant will be re-evaluated at an expert center, where blood biomarkers of NDD will be
collected. We will support PC practitioners to provide a biomarker-informed diagnostic disclosure to each
patient. We will examine the accuracy of PCP diagnoses, using expert opinions and biomarkers as the gold
standard, and evaluate the feasibility of toolkit use in the practices through surveys, interviews, and focus
groups. To help address the sensitivity of pre-visit questions to atypical symptoms of NDD, we will also recruit
200 patients with atypical presentations at UCSF. Achievement of the project goals will establish an efficient
model for earlier, etiologically-specific diagnosis of cognitive and behavioral changes due to Alzheimer’s
disease and other NDDs.

Public health relevance
PROJECT NARRATIVE This project will benefit public health by supporting improved diagnosis and more rapid recognition of dementia due to Alzheimer’s disease and related disorders in primary care settings.